COMMUNICATIONS AND OUTREACH SERVICES CONTRACT

Communicate Health provides support to the NEI Office of Science Communications, Public Liaison, and Education for programs including the National Eye Health Education Program